THE MOLECULAR MECHANISMS FOR MALIGNANT TRANSFORMATION OF CELLS

The goal of this project is to investigate the molecular mechanisms underlying the malignant transformation of cells. We have been studying the structure and function of the tumor antigen (T-antigen) encoded by simian virus 40 (SV40). Using either recombinant viruses which contain different parts of the T-antigen gene or proteolytic enzymes which cleave the T-antigen molecule at specific sites, we were able to dissect and identify the roles of the various domains of the multifunctional SV40 T-antigen.